Enhancing Environmental Health Literacy and Practice for Healthcare Providers: An Innovative CME Series

Ample evidence demonstrates that toxicants and other environmental exposures lead to both acute and chronic health
conditions. This proposal is a direct outgrowth of our experience with a community heavily exposed to chemical
toxicants. We have demonstrated significant adverse health outcomes associated with this exposure. However, many
community members report a lack of knowledge and skills among their healthcare providers to address their exposure-
related health risks. These reports are consistent with documentation that healthcare providers (HCPs) rarely address
environmental concerns with patients and report a lack of knowledge and ability regarding these patient concerns. These
knowledge and practice gaps are not surprising since few nursing or medical schools include environmental health
training in their curricula. As such, there is a critical need to expand healthcare provider training in environmental health.
To address this critical need, we will develop an innovative continuing medical education (CME) series. The innovation is
two-fold. First, we will partner with impacted community members to develop patient-centered and community-centered
material, focusing on lived experiences of community members and their healthcare providers. Second, we will utilize
interactive and engaging tools to facilitate learning and integration into practice. The series will be titled “Understanding
and mitigating the impact of environmental chemicals on the health of your patients.” We will design CME learning
experiences that are both evidence-based and informed by years of online teaching experience. To ensure the relevance of
the content to patients and HCPs, members of communities affected by endocrine-disrupting chemicals and HCPs in these
communities will be involved throughout the entire cycle of course design, development, piloting, and evaluation.
Additionally, their voices and stories will be featured in images, audio, and video assets in the course. This Phase One
SBIR grant will develop and design the first module of the CME series titled “How Endocrine Disrupting Chemicals from
the Environment act as Uncontrolled Medicine in Your Patients.” We will also develop pocket guides, job aids, and
infographics that can be easily downloaded to assist in translating learning to clinical practice. Pilot testing for usability
and scalability will also be completed. This project will generate an engaging, easily-accessible, informative course to
introduce HCPs to important environmental health concepts related to endocrine-disrupting chemicals, which will provide
HCPs with the ability to address patients’ health concerns. If successful, this project will improve health outcomes and
save lives by giving healthcare providers the knowledge and tools to protect their patients from preventable impacts of
environmental exposures to endocrine-disrupting chemicals.

Public health relevance
This project will address a significant gap in environmental health literacy among frontline healthcare providers. It grew out of the needs of an exposed community engaged in a partnership with Emory environmental health scientists. The scientists have partnered with Full Tilt Ahead, a small business specializing in innovative instructional methods. If successful, this project will improve health outcomes by giving healthcare providers the knowledge and tools needed to protect their patients from preventable impacts of environmental exposures.